Core C: Microbial Engineering and Transplantation Core

Microbial Engineering and Transplantation Core (Core C). ABSTRACT:
The overall goals of the Microbial Engineering and Transplantation Core are to maintain and develop
bacterial strains, including model synthetic communities, and provide complex polymicrobial
communities for transplantation, as well as to assist in all aspects of gnotobiotic reconstitution
(microbial transplantation) studies for Project Investigators. All projects in this PPG involve
transplantation of native or genetically manipulated bacterial species, either singly, as polymicrobial
communities, and/or synthetic bacterial communities harboring selective metabolite-producing capabilities (or
functional deletion mutants) into germ-free mice (i.e. gnotobiotic reconstitution). Anaerobic culturing and
microbial engineering, as well as germ-free mouse derivation, maintenance, and microbial transplantation, are
all complex features of intricate experiments that require specialized expertise, and infrastructure. The
Microbial Engineering and Transplantation Core will provide all of these services to investigators of this PPG.
The microbial culturing and engineering component of the Core will assist investigators with centralized
anaerobic culturing capabilities for both in vitro metabolic/biochemical, and in vivo microbial transplantation
studies. Each Project will also draw on this core for its expertise and assistance with genetic engineering of
human commensals as needed. The gnotobiotics component of this core will assist all Projects in performance
of gnotobiotic reconstitution studies, and their interface with cardiometabolic phenotyping studies (in Core D).